Biomarker Candidates in Gulf War Veterans: A 10-year Follow-up Investigation

Clinical investigations examining biomarker candidates in Gulf War Veterans' Illnesses (GWVI) are limited,
and studies that encompass both baseline and 10‐year follow‐up data for blood biomarker candidates are
currently unavailable. We thus propose to conduct a 10‐year follow‐up investigation in Gulf War Veterans
to examine promising blood biomarker candidates at baseline and 10‐year follow‐up, a project that has the
potential to be rapidly catalyzed into clinically efficacious interventions for GWVI.
Our preliminary baseline data in serum samples collected 2005 ‐ 2014 from Veterans who served in the Gulf
War era (1990‐1991) suggest significant differences in a number of biomarker candidates in Veterans who
had been deployed to the Gulf War theater (compared to Veterans who had served in the 1990‐1991 Gulf
War era, but who had not been deployed to the region of conflict). Baseline pilot studies suggest that
Veterans with a history of deployment to the Gulf War theater demonstrate: a.) altered neurosteroid
metabolism, possibly secondary to endocrine disruption involving chemical agent exposures (among other
potential etiologies), b.) reductions in Vitamin D (implicated in processes relevant to GWVI, including
inflammation, cancer, and environmental exposures, c.) elevations in acylcarnitines and other endogenous
esters (potentially signaling mitochondrial changes), and d.) elevations in c‐reactive protein (a marker of
inflammation likely relevant to GWVI). Our recent data demonstrate that many of these analytes are also
significantly associated with possible symptoms of GWVI, further strengthening the rationale for this project.
All of these biomarker candidates have the potential to be rapidly translated into new treatments for GWVI,
consistent with Institute of Medicine's (IOM) recent recommendations that “Future Gulf War research should
place top priority on the identification and development of effective therapeutic interventions and management
strategies for Gulf War illness” (2016). We thus propose to examine biomarker candidates at baseline and also
at 10‐year follow‐up in Veterans of the 1990‐1991 Gulf War era to inform therapeutic development.
1. Based on strong pilot data, we propose to conduct baseline biomarker investigations in 527 Gulf War era
Veterans for whom serum samples are already collected. We hypothesize that we will replicate our pilot findings
showing alterations in neurosteroid metabolism, Vitamin D, acylcarnitines, and inflammatory markers in Gulf War
Veterans with a history of deployment to the Gulf War theater of operations.
2. As 94% of the 527 Gulf War era Veterans who provided a blood sample between 2005 – 2014 have
already provided explicit permission to be re‐contacted for future research studies (i.e. agreeing to this in
the consent form of the original 2005 – 2014 study), and as our recent feasibility study shows that 75% of
previously enrolled Veterans can indeed be successfully re‐contacted and are also willing to participate in
new research studies, we propose to conduct a 10‐year follow‐up study (+/‐ 2 years) in 400 Gulf War
Veterans to determine if biomarker changes in Veterans with a history of deployment persist 10 years later,
and potentially predict pain, cognitive symptoms, general medical health, and functional outcomes.
3. Exploratory: Of the 527 Gulf War era Veterans in the proposed cohort, approximately 20% had baseline
neuroimaging studies during the 2005 – 2014 interval (structural MRI +/‐ DTI). Our preliminary data
suggest that neurosteroid levels in blood are relevant to brain structure and function. We thus propose to
conduct 10‐year follow‐up MRI and DTI assessments in 50 Gulf War Veterans for whom baseline
neuroimaging studies conducted during the 2005 – 2014 interval are currently available.
These biomarker investigations could contribute to identifying new treatment interventions for GWVI that
are mechanistically anchored and address pathophysiological alterations relevant to the condition. They
could also function as predictors of GWVI symptoms and therapeutic response.

Public health relevance
Clinical investigations examining biomarker candidates in Gulf War Veterans' Illnesses (GWVI) are limited, and studies that encompass both baseline and 10‐year follow‐up data for blood biomarker candidates are currently unavailable. We thus propose to conduct a 10‐year follow‐up investigation in Gulf War Veterans to examine promising blood biomarker candidates at baseline and 10‐year follow‐up, a project that has the potential to be rapidly catalyzed into clinically efficacious interventions for GWVI. These biomarker investigations could contribute to identifying new interventions for the treatment of GWVI that are mechanistically anchored and address pathophysiological alterations relevant to the condition. They could also function as predictors of GWVI symptoms and therapeutic response to new treatments.